Improving usage of the Aphasia Research Cohort (ARC) repository

Project Summary/Abstract
The Center for the Study of Aphasia Recovery (C-STAR) explores recovery from language
impairments following stroke. Over the course of the last 18 years, through both internally
supported and NIH-funded awards, this database has grown to include over 5700 MRI scans
from 250 stroke survivors. This trove of data is publicly accessible to researchers and scientists
around the world via the OpenNeuro NIH-supported biomedical data repository known as the
Aphasia Recovery Cohort (ARC). Historically, clinical neuroimaging has been analyzed by
small, siloed teams like our own, who have developed specialized tools to handle the unusual
properties of clinical data. Our objective is to develop a framework that will allow scientists
around the world to process and analyze clinical neuroimaging datasets to make new
discoveries. By creating a pipeline that handles the common pitfalls, experts from other domains
can contribute innovative solutions, creating a virtuous feedback cycle. Our framework will also
help other clinical teams share and exploit their datasets, easing compliance with resource
sharing plans and exploiting large distributed datasets. By increasing compliance with FAIR
(Findable, Accessible, Interoperable, and Re-usable) principles, we will increase the ability of
researchers to examine not only our stroke data, but also stroke data from other repositories.
Specifically, we will leverage NeuroDesk, an online platform preinstalled with image-processing
software to disseminate a novel stroke-specific processing and analysis package, lesionPrep,
which will facilitate usage of the ARC and similar datasets.

Public health relevance
Project Narrative This proposal will help other teams exploit the Aphasia Recovery Cohort (ARC) repository to better understand the consequences of brain injury. Specifically, we will provide a processing and analysis pipeline that avoids the pitfalls specific to clinical datasets. This will allow non- clinical teams to translate their cutting edge tools to help understand stroke. These teams will have the option of contributing their innovations to the framework. Clinical teams can benefit from this virtuous cycle and will also have a concrete template for contributing their own datasets. This project will dramatically increase Accessibility, Interoperability and Re-usability of the ARC dataset, and have positive repercussions on stroke research.